NEURAL SYSTEMS SUPPORTING SPEECH PROCESSING IN LISTENERS WITH COCHLEAR IMPLANTS

Abstract Approximately 36 million Americans report having some degree of hearing impairment. Hearing impairment is associated with social isolation, depression, and cognitive decline. The toll of hearing impairment is not only personal, but economic: For Americans who have hearing impairment, the lifetime cost is estimated to be $4.6 billion, mostly due to reduced work productivity. Listeners with hearing impairment can often understand spoken language, but with increased effort, taking cognitive resources away from other processes such as attention and memory. An important challenge is therefore to understand how the brain copes with a degraded speech signal and the cognitive processes that are most critical to successful comprehension. Adult listeners with cochlear implants are a unique group in which to investigate effortful listening: They have typically adapted to auditory deprivation for a period of years of profound hearing loss, followed by some degree of hearing restoration following implantation. Following increased auditory input due to cochlear implantation, the degree to which individual listeners are able to successfully recognize speech, especially in the presence of background noise, is extremely variable. Previous attempts to explain this variability in the context of underlying patterns of brain activity have been unsuccessful, in large part because the technical challenges associated with neuroimaging in the presence of an implanted medical device have prevented adequate localization of neural responses to speech. The goal of our research is to understand the cognitive systems that support speech recognition in listeners with cochlear implants and to use knowledge about these systems to improve behavioral outcomes. We do so using converging evidence from behavioral measures and functional brain imaging. We make use of high-density diffuse optical tomography (HD-DOT), a form of optical brain imaging that produces anatomically-localized indices of regional cortical activity. We will map the neural systems supporting speech comprehension in listeners with cochlear implants, which we expect to differ from those engaged by listeners with good hearing. We will then evaluate the degree to which neural markers of effortful listening can predict individual differences in speech recognition success in the presence of background noise. Together the findings will help ground our understanding of cochlear implant-aided speech recognition in a neuroanatomically-constrained framework and develop more accurate outcome measures.

Public health relevance
Narrative Listeners with cochlear implants vary in their success at understanding spoken language, particularly in the presence of background noise. Although neural reorganization and compensation are certain play important roles in their performance, the brain networks that support successful speech comprehension in cochlear implant recipients have proven difficult to localize and study due to the technical limitations caused by the implanted hardware. The current studies use a combination of behavioral and optical imaging techniques to map the neural systems supporting speech perception in cochlear implant recipients, which will help us to better understand and treat speech comprehension difficulty in people with a variety of hearing impairments.